Molecular and Cellular Mechanisms of Copper-Dependent Nutrient Signaling and Metabolism

Molecular and Cellular Mechanisms of Copper-Dependent Nutrient Signaling and Metabolism
PROJECT SUMMARY/ABSTRACT
Akin to organic nutrients, such as oxygen, lipids, amino acids, and carbohydrates, the transition metal copper
(Cu) is an essential dietary nutrient for normal physiology and development. Decades of research highlight the
physiological and disease associated consequences of disrupting homeostatic mechanisms that ensure proper
Cu acquisition, storage, and distribution to Cu-dependent enzymes. However, phenotypes associated with
alterations in Cu availability cannot be fully explained by the limited number of enzymes that traditionally harness
the redox potential of Cu as a catalytic cofactor. Recent discoveries in Cu biology have revealed direct Cu binding
at non-catalytic sites within signaling molecules that modulate cell proliferation via the protein kinases MEK1/2,
lipid metabolism via the phosphodiesterase PDE3B, and nutrient recycling via the autophagic kinases ULK1/2.
The emergence of this new paradigm in nutrient sensing and protein regulation has established that Cu is a
critical mediator of intracellular signaling, provided evidence for the existence of molecular mechanisms for
sensing changes in Cu abundance, and expanded the contribution of Cu to cellular processes necessary for
adaptation to nutrient scarcity. This grant proposal will focus on the intersections between Cu homeostasis,
nutrient signaling, and metabolism by examining the interplay between mechanisms of Cu-sensing necessary
for cellular energy homeostasis and evaluating the necessity of Cu for metabolic flexibility under nutrient and
oxygen stress. Specifically, we will build on our novel findings from the past 5 years by elucidating mechanisms
of: i) Cu-controlled autophagy-lysosomal biogenesis and function, ii) Cu-mediated metabolic flexibility via direct
control of glycolytic flux, and iii) interconnectivity between mitochondrial Cu transport and cytosolic nutrient
sensing signaling pathways necessary for metabolism. By launching these three interconnected focus areas, we
will increase our fundamental knowledge of the molecular and cellular features of Cu-dependent enzymes
and cellular processes and enable therapeutic targeting of Cu-dependent disease vulnerabilities.

Public health relevance
Molecular and Cellular Mechanisms of Copper-Dependent Nutrient Signaling and Metabolism PROJECT NARRATIVE The transition metal copper (Cu), which is acquired as a dietary nutrient, contributes to the balance between cell proliferation and cell death that is essential for life. An emerging paradigm in nutrient sensing and protein regulation, termed metalloallostery, whereby protein activity is controlled by Cu at non-catalytic sites has expanded the contribution of Cu to signaling events and enabled therapeutic exploitation of Cu-dependent disease associated cellular processes. This proposal will build on this new and clinically relevant signaling paradigm by delineating molecular and cellular mechanisms that underlie Cu-dependent adaptations to nutrient scarcity that are critical for sustaining energy balance for survival under physiological conditions and in diseases settings.